Bioanalytics, Metabolomics and Pharmacokinetics Shared Resource

The PK/PD Shared Resource was renamed to the Bioanalytics, Metabolomics and Pharmacokinetics Shared
Resource (BMPK) in 2015 as a result of strategic planning process and discussions at the Shared Resource
Directors Committee. The re-organization has allowed BPMK to offer a more comprehensive array of services
that now includes targeted metabolomic analyses. The overall goal of BMPK is to provide specialized
bioanalytical and modeling expertise that enhance scientific interaction and productivity within the Roswell Park
Comprehensive Cancer Center (Roswell Park). BMPK maintains a wide range of state-of-the-art instruments
that are typically outside the reach of individual investigators. BMPK has established 46 Standard Operating
Procedures for method development and validation, equipment maintenance and calibration, sample inventory
and tracking, staff training, and quality assurance. BMPK developed several new bioanalytical methods that
supported various clinical trials and basic research studies for all five CCSG programs during the current
reporting period. These assays include tyrosine kinase inhibitors, mTOR inhibitors, topoisomerase inhibitors,
gemcitabine, taxanes, doxorubicin, sorafenib, finasteride, dutasteride and enzalutamide. BMPK also offers
bioanalytical assays to support chemoprevention studies, such as erlotinib for the prevention of lung cancer
and lignans for prevention of breast cancer. BMPK served a total of 42 Roswell users, of which 39 (96%) were
CCSG members. The Specific Aims of BMPK are: 1) To provide state-of-the-art support for discovery-based
research, pre-clinical/clinical drug development and translational pharmacology through generation of high
quality bioanalytical data, metabolomic profiling and PK/PD modeling of results; 2) To provide a highly
collaborative approach to utilization of shared resources to maximize efficiency and data outcomes for
researchers; 3) To co-integrate BMPK results with those of other shared resources to advance our overall
understanding and knowledge of translationally-related clinical cancer outcomes. BMPK is critical to the drug
development/clinical trial effort at Roswell Park. We plan to maintain state-of-the-art technology to address the
research interests of investigators; routinely implement fast LC-MS/MS techniques to improve overall
throughput of studies; expand the number of validated assays and targeted metabolomic profiles while
implementing untargeted metabolomics and proteomics; strengthen educational and training efforts; and
develop essential PK/PD models and simulations to relate temporal relationships of drug and biomarker
concentrations, antitumor response to different dosing strategies to optimize efficacy while minimizing toxicity
in an effort to translate drug combination therapies from bench to bedside.